Research Capacity Core

ABSTRACT
The Research Capacity Core (RCC) is a distributed core facility that is capable of providing a broad cadre of
services and resources to basic biomedical, behavioral, population science and clinical research projects
throughout Howard University for the support of minority health and health disparities research. To do so, the
RCC will connect researchers throughout the institution with facility resources and research support necessary
to conduct cutting-edge research in minority health and health disparities. The specific aims of the RCC are: 1)
provide core research services and resources in the areas of Computational Biology & Bioinformatics (CCBB),
Clinical and Health Informatics (Outcomes Research Center, ORC), Imaging, and Proteomics; 2)
systematically distribute this research support to HU RCMI research project investigators, Investigator
Development Core pilot project awardees, and other MHHD investigators across the Howard University
campus; and 3) evaluate utilization and efficacy of the available research infrastructure support. In addition to
impacting research across the entire Howard campus, the RCC will specifically enhance the quality and
productivity of the pilot projects to be funded through the Investigator Development Core and the HU RCMI-supported
research projects. Additionally, the requested infrastructure support builds upon previously funded
HU RCMI resources by extending data science services and resources. In order to ensure that the RCC
functions at a level of maximal efficiency, it will be important to obtain feedback from users regarding its
operational effectiveness. This will be achieved via annual evaluative assessments of RCC’s contribution to
Howard University’s research effort via tracking of pre-established metrics: projects supported, publications
and presentations, funded grants, and grants submitted. Each RCC module will be tracked and evaluated
individually, and the modular data will then be combined in a comprehensive RCC report. The approach of
modular evaluations will allow for strategic interim adjustments to individual modules, as needed. The
evaluation of common data elements (CDEs) will allow for comparison of the HU effort with the RCMI
Coordinating Center Consortium (RCMI-CC).